Administrative Core

C-EARTH Administration Core Summary/Abstract:
The success of the Center for Climate: Equitable and Accessible Research-based Testing
for Health (C-EARTH) will depend largely on efficient communication, planning, and synergy
among the project, cores, and activities. To accomplish this, the Administrative Core will
provide an infrastructure for logistical and scientific oversight, coordination, and integration of C-
EARTH, ensuring the synthesis of C-EARTH components and activities towards solutions-
oriented translation of findings in support of two themes of the P20 RFA: 1) to investigate the
feasibility, acceptability, uptake, and spread of interventions to promote preparedness and
adaptation to anticipated health impacts of climate change at individual, community, regional, or
national levels; and 2) to explore climate-related vulnerabilities in nutritional security in
disadvantaged communities to inform culturally sensitive and sustainable solutions. The
Administrative Core will serve as a central forum for communication among investigators across
the project and cores, coordination to establish and maintain partnerships to engage
communities most likely to be impacted by climate change, and active participation in the NIH
Research Coordinating Center. We will also carry out career development plans and
evaluations for our early stage faculty and researchers. The core’s activities will ensure
sustainable research capacity by managing the utilization of centralized resources and research
infrastructure. The Administrative Core will also oversee a robust data infrastructure and
management plan, providing the framework necessary for seamless data management, sharing,
and analysis. In particular, the Administrative Core will implement innovative databases and
tools for climate readiness for communities and for mapping high-resolution apparent
temperature at scale. These resources will support the research and core activities throughout
C-EARTH. With a strong supportive structure in place, C-EARTH will create a premiere
environment for translational research on the health consequences of climate change.